Targeting Surgical Site Infections through a Perioperative Antibiotic Clinical Decision Support Tool

PROJECT SUMMARY / ABSTRACT
More than 500,000 patients acquire Surgical Site Infections (SSIs) each year, making them the leading cause
of hospital-acquired infections. SSIs account for billions of dollars in added health care costs and are
associated with up to 11 times higher risk of post-surgical mortality. Despite near universal adherence to
Surgical Care Improvement Project (SCIP) guidelines for prophylactic antibiotic administration, SSI rates
remain stagnant. As compared to SCIP, the Infectious Disease Society of America (IDSA) provides far more
comprehensive guidelines for surgical antibiotic prophylaxis. Beyond the SCIP measures, which focus mostly
on antibiotic timing with respect to surgical incision, IDSA guidelines additionally include: 1) more specific
antibiotic selection for several surgical procedures, 2) weight-adjusted antibiotic dosing, and 3) timely antibiotic
re-dosing during prolonged surgeries. Each of these is a crucial aspect of antibiotic administration and is not
addressed by SCIP guidelines that inform the majority of perioperative antibiotic practice. In preliminary work
using a national dataset, we found that non-adherence to at least one of the components of IDSA guidelines
occurred in over one-third of surgical cases. We also found that IDSA non-adherence is markedly higher during
unplanned scenarios such as surgeries involving multiple blood product transfusions and emergency surgeries
indicating there may be a situational component to the non-adherence. We believe promoting adherence to
IDSA guidelines can markedly reduce SSIs and can be achieved by targeting healthcare provider workflow
barriers and knowledge deficits using a provider centered clinical decision support (CDS) tool. We propose to -
Aim 1: Measure the association of nonadherence to IDSA guidelines and its components (antibiotic choice,
timing, dosing, and intraoperative redosing) with SSI occurrence by analyzing merged data from two robust
national registries: the National Surgical Quality Improvement Program (NSQIP), which captures detailed
postoperative outcomes, with the Multicenter Perioperative Outcomes Group (MPOG) that captures detailed
perioperative data. Additionally, we will examine differences in nonadherence (disparities in care) across
several AHRQ priority groups to identify opportunities for SSI reduction within these subgroups. Aim 2: Identify
factors associated with deviation from IDSA guidelines in practice through semi structured interviews of
perioperative healthcare providers and incorporate these to develop a CDS tool that promotes IDSA adherent
antibiotic practices. Aim 3: Assess the real-world performance of the CDS tool and provider feedback using
the RE-AIM (Reach, Effectiveness, Adoption, Implementation, Maintenance) framework of implementation
evaluation. Public Health Significance: SSIs are common, costly, and largely avoidable. The proposed study
will a) help determine relationships between IDSA guideline nonadherence and SSIs including among AHRQ
priority groups; b) identify barriers to guideline adherence; and c) test a readily usable intervention for
implementation in a future large pragmatic trial powered to detect reduction in SSI outcomes.

Public health relevance
PROJECT NARRATIVE Antibiotic prophylaxis at the time of surgery is a critical component to reduce Surgical Site Infections (SSIs). Although explicit guidelines from the Surgical Care Improvement Project (SCIP) have near universal adherence, these guidelines do not encompass key components of antibiotic best practice as recommended by the Infectious Disease Society of America (IDSA). The present application examines the association of IDSA-nonadherence with SSIs in a nationwide sample and envisages the development and testing of an Electronic Health Record (EHR)-based intervention based on healthcare provider needs, to improve guideline adherent perioperative antibiotics prophylaxis and decrease rates of SSIs.